BIOREPOSITORY CENTER

PROJECT SUMMARY (See instructions): The overarching goal of the BioRepository Center (BRC) is to facilitate translational research. Tight coordination between surgical staff, pathologists, and BRC enables collection of specimens to fulfill investigators' needs. Our protocols for rapid acquisition of tissue samples allows for preparation of high quality analytes. Patients' rights and privacy by our participation in obtaining and confirming informed consent for tissue collection; guidance with regard to preparation and submission of IRB documents is offered to help ensure compliance. The BRC also promotes collaborations between clinical and basic scientists, and can aid in the design and execution of prospective, hypothesis-driven studies to examine the impact of genetics or treatment on disease progression. By promoting investigators access to appropriate biospecimens, the BRC enhances the ability of NYULMC Cancer Institute members to perform meaningful translational research.

Public health relevance
RELEVANCE (See instructions): The BioRepository Center (BRC) plays a critical role in promoting translational research at NYU Cancer Institute (NYUCI). By coordinating with surgeons and other clinicians, we help scientists obtain human tissues that they need. This allows for investigations of pathologic processes or novel therapeutics, with the most relevance to human disease, and linking and expanding findings initially discovered in model systems.